Georgia Clinical & Translational Science Alliance (GaCTSA)

Project Summary / Abstract In response Notice of Special Interest: Clinical and Translational Science Award (CTSA) Program Administrative Supplements (NOT-TR-20-014), the Georgia CTSA proposes to create a dedicated quality assurance/quality control position to perform quality reviews of CTSA-related submissions to NCATS, submissions to the eRA Human Subjects System, and management of the overall process.

Public health relevance
Project Narrative The CTSA Program supports a national consortium of medical research institutions that work together to tackle system-wide scientific and operational changes that solve the many outstanding problems limiting the efficiency, effectiveness, and reach of clinical translational research, and thus get more treatments to more patients more quickly across the country. Towards the effort of focusing on widely appreciated systematic barriers, the Georgia CTSA proposes to add a dedicated quality assurance/quality control position to perform quality reviews of Georgia CTSA-related submissions to NCATS, submissions to the eRA Human Subjects System, and management of the overall process.